3rd International Symposium on Neglected Influenza Viruses

? DESCRIPTION (provided by the applicant): There is considerable and justifiable concern that neglected influenza viruses or their hosts will contribute to human and animal pandemic threats. Examples are the triple reassortant variant H3N2 influenza viruses that continue to transmit from pigs to children, the spread and detection of novel avian-like H5, H6, and H9 influenza viruses in pigs worldwide, the emergence of a potentially pandemic H3N8 influenza virus from seals in the Northeastern US, and the recent identification of a new Orthomyxoviridae C/D virus from cows and exposed humans. The purpose of this proposal is to provide funds to support travel awards for invited speakers and young scientists to present and attend the 3rd International Symposium on Neglected Influenza Viruses, which will be held in Athens, GA April 15th - 17th, 2015. In this Symposium, we will explore these neglected influenza viruses and viral circulation in their hosts. This meeting will provide an opportunity to bring together scientists from around the world with interests in the field of orthomyxoviruses, stimulate collaboration, and foster a commitment to this area of research. It will be especially important to encourage a new generation of young scientists to not only study influenza viruses, but to focus on the neglected influenza viruses. Although there are a number of meetings dedicated to influenza virus, this is the only meeting focused on neglected influenza viruses and encouraging young investigator participation making it unique. If successful, we will be able to provide financial support to a typically understudied and underrepresented area of research with significant public health concerns.

Public health relevance
PUBLIC HEALTH RELEVANCE: Influenza viruses are major public health and veterinary/agricultural threats associated with considerable morbidity and mortality worldwide. In spite of this threat, our understanding of the non-avian, non-human influenza viruses (i.e. "neglected" viruses), their hosts, unique and emerging Orthomyxoviridae family members, and risk to humans is incomplete. Surprisingly, this includes information on swine influenza viruses, which we know are major threats to human health including the variant H3N2 influenza viruses that are again transmitting from pigs to children at state fairs throughout the Midwestern US. The 3nd International Symposium on Neglected Influenza Viruses to be held at the Georgia Conference Center in Athens GA April 15th - 17th 2015 will explore these neglected influenza viruses, their hosts, and impact on public health. This meeting is unique in its focus upon neglected influenza viruses and bringing together public health, veterinary and agriculture experts with epidemiologists, ecologists, and experimentalists from around the world. The first symposium was held at Amelia Island, Florida in February 2010 and the 110 participants from 13 countries found it one of the most rewarding influenza meetings they had ever attended. The second meeting in 2013 in Dublin, Ireland received similar accolades. Both meetings resulted in highly cited proceedings in "Influenza and Other Respiratory Viruses." This meeting will provide an opportunity to bring together scientists from around the world with interests in the field of orthomyxoviruses, stimulate collaboration, and foster a commitment to this area of research. It will be especially important to encourage a new generation of young scientists to not only study influenza viruses, but to focus on the "neglected" influenza viruses. Session topics include surveillance and disease investigation, virus transmission and control, clinical and experimental virology, and emerging issues and new developments. The conference will be held at an easily accessible but exclusive site providing an intense 2 days of interaction and exchange of ideas. Worldwide problems due to influenza including the certainty of an incipient pandemic, continuous economic loss from influenza, identification of new host species (bats and cows) and viral species (Orthomyxovirus C/D), and continuing debate about gain-of- function/DURC/biosafety issues make these important topics for present and future study. The purpose of this proposal is to provide funds that support this understudied area of influenza research and allow promising young investigators to interact with their peers and develop a commitment to this area of research.